A Bedside Relational Agent to Improve Hematopoietic Cell Transplantation Outcomes in Cancer Patients

Abstract
Delirium, a major cause of falls, can occur in as many as 50% of cancer patients undergoing stem cell
transplantation, resulting in up to 14 times greater chance of dying. Delirium risk can be mitigated and many
other outcomes of stem cell transplants can be improved through behavioral interventions delivered at the
bedside through conversation, imagery, and audio. However, traditional means of delivering these
interventions are very labor intensive, difficult to quality control, and difficult to cost-effectively scale to many
patients. In this SBIR Fast-Track proposal, we seek to develop a technology-enabled bedside digital relational
agent specifically programmed to enhance the well-being, safety, and outcomes of cancer patients undergoing
inpatient stem cell transplantation, by supporting them through protocols in the following eight categories: Diet
& Hydration, Physical Exercise, Incentive Spirometry, Orientation, Non-Pharmacological Pain & Anxiety
Management, Psychosocial Support & Staff Communication, Sleep, and Toileting Assistance. We will then
conduct a three-year clinical study, deploying this new intervention to over 200 adult patients across two
oncology/hematology units, aiming to observe (compared to a randomized control group) statistically significant
reductions in length of stay, incident delirium rate, fall rate, anxiety, depression, and loneliness, with improved
overall patient satisfaction and rate of immune system recovery post-transplant. This proposal addresses the
major National Cancer Institute portfolio areas of “Technologies for Cancer Control (Behavioral Health
Interventions)” and “Digital Health (Mobile Health and Health Information Technology).”

Public health relevance
Narrative Delirium, a major cause of falls, can occur in as many as 50% of cancer patients undergoing stem cell transplant, resulting in up to 14 times greater chance of dying. Delirium risk can be mitigated and many other outcomes of stem cell transplants can be improved through behavioral interventions delivered at the bedside through conversation, imagery, and audio. care.coach™ is developing a technology-enabled cancer care platform that provides 24x7 proactive bedside support for patients undergoing stem cell transplants, to mitigate delirium and falls while improving recovery through better adherence to diet, exercise, and other best practices, in a scalable, cost-effective manner.